HYPOGONADISM IN MEN WITH LUNG CANCER

To develop preliminary evidence to support the hypothesis that hypogonadism is common in men with lung cancer and is related to malnutrition and adverse clinical outcome. To estimate the frequency of hypogonadism in men with lung cancer and to define the role of hypogonadism in lung cancer prognosis.